Mechanisms of macrolide synergy in Mycobacterium tuberculosis

ABSTRACT
I have been fortunate to combine my passions for scientific research and public health in my doctoral
studies at the Harvard T. H. Chan School of Public Health. My goal is to combine creativity and technical skills
in drug discovery efforts against infectious diseases of high morbidity and mortality. Dr. Eric Rubin's lab is the
archetype for rigorous scientific training and creative problem-solving. He and I have established my core training
goals. I hope not only to complete my proposed research plan, but also to continue sharpening skills in grant
and paper writing, collaboration, critical thinking, and quantitative data analysis. An F31 Fellowship will propel
me in my journey to become a principal investigator in the field of antibiotic research and discovery.
Mycobacterium tuberculosis (Mtb), which causes tuberculosis (TB), has been a leading cause of
infectious disease morbidity and mortality for thousands of years. One major reason for its global persistence is
the fact that Mtb is intrinsically resistant to most antibiotics. Current treatment requires months of combination
therapy with drugs almost exclusively reserved for TB and that are not well-tolerated by patients. The high
morbidity, mortality, and the growing prevalence of acquired drug resistance in TB motivate an urgent search for
new drugs. If bacterial targets could be identified that synergize with existing drugs, such as to bring efficacy to
antibiotics not currently effective against TB, they could advance our goal of treatment improvement. I have used
a genetic approach to identify an essential Mtb enzyme that, when depleted, sensitizes this pathogen to existing
antibiotics. Here, I propose to characterize the mechanisms of synergy between this Mtb gene and macrolide
antibiotics, which bind the 50S ribosomal subunit to inhibit translation. Macrolides are inexpensive and well-
tolerated antibiotics used to treat other infectious diseases. My gene of interest, pth, encodes the essential
enzyme peptidyl tRNA hydrolase, a translation rescue factor that cleaves tRNA from peptides when they are
prematurely released from stalled ribosomes. My approach to studying Pth as an antibiotic target draws on
existing analytical techniques, as well as a new method using tRNA-sequencing that I have developed for
studying charged tRNA pools. Investigating synergistic drug targets and their mechanisms of interaction will
allow us to lend new efficacy to old compounds in the fight against TB. Additionally, new tools to study tRNA will
allow us to expand our understanding of translation machinery in other organisms.

Public health relevance
PROJECT NARRATIVE Tuberculosis continues to pose a major global health threat because the causative pathogen, Mycobacterium tuberculosis (Mtb) is intrinsically resistant to most antibiotics used to treat other infectious diseases. My goal is to understand the mechanisms underlying genetic pathways in Mtb that contribute to its resistance to certain antibiotics, to inform drug discovery efforts. As a graduate student, I hope not only to complete my proposed research plan, but also to continue sharpening skills in grant and paper writing, collaboration, critical thinking, and quantitative data analysis.